Training in Advanced Data Analytics to End Drug-Related Harms (TADA)

Abstract: Collins and Riley, Directors of NIH and of NIH’s Office of Behavioral and Social Science Research,
have described the 21st century data revolution as potentially “transformative” for social and behavioral science
(SBS) research. Evolutionary leaps in technology have generated vast arrays of novel sources of Big Data: in
2018, for example, 500 million microblogs were tweeted daily, and 2.48 billion users engaged with Facebook.
The data revolution has also catalyzed massive growth in administrative data, as governments and other
entities digitize their data (e.g., the CDC has data on billions of prescriptions dispensed in the US). Constella-
tions of tweets, posts, and administrative data provide “transformative” opportunities for SBS researchers to
swiftly identify threats to health; characterize-more comprehensively than ever before, and often in real time-
the conditions in which people thrive, suffer, and die; and develop novel interventions.
Nowhere are such transformations more direly needed than to address a 21st century crisis: substance
use disorders (SUD). In 2017, HHS declared the opioid crisis a national emergency, as 11.4 million people
misused opioid analgesics, and overdoses killed >70,000 people, contributing to a drop in US life expectancy.
We are, though, failing to prepare the next generation of SBS researchers to engage these transforma-
tive tools. A scan of syllabi from departments of behavioral and social science in 10 top public health schools
reveals that required methods courses culminate with multilevel and structural equation models, decades-old
methods ill-equipped to leverage emerging data to catalyze transformative approaches to end SUD epidemics.
Supported by 45 Emory faculty from 11 departments, the proposed training program (TADA) will
prepare a diverse cadre of 21st century SBS researchers to develop transformative approaches to end the SUD
crisis. TADA will prepare trainees to ethically, critically, and seamlessly integrate advanced data science
methods into the SBS research lifecycle for SUD. Trainees will learn to: (1) Conduct theoretically-informed
studies of distributions and ecologies of SUD-related harms using advanced data science methods; (2)
Conduct theoretically-informed studies motivating and assessing policies and programmatic interventions that
may affect SUD-related harms and services; (3) Disseminate findings to multiple stakeholder communities to
strengthen efforts to end SUD-related harms; (4) Critically apply principles of the ethical and responsible
conduct of research. TADA will engage trainees in a comprehensive mentoring program; a 2-semester course
and lab consisting of 5 “modules,” each of which pairs a specific SBS theory with an advanced data science
method; journal clubs; dissertation workshops; $5000 dissertation grants; and research rotations at Emory, the
CDC, and the Georgia DPH. We are seeking 5 funded slots across two cohorts, each with 2 years of funding,
for pre-doctoral students in 4 programs (Behavioral Science, Health Policy, Sociology’s Health Track, and
Clinical Psychology). TADA will extend its reach beyond funded trainees via a TADA Certificate program.

Public health relevance
Narrative: The proposed program “Training in Advanced Data Analytics and Computational Sciences to End Drug-Related Harms” (TADA) will prepare a diverse cadre of 21st century social and behavioral science (SBS) researchers to develop transformative approaches to end the substance use disorder (SUD) crisis. Supported by 45 faculty mentors from 11 departments, TADA will prepare trainees to ethically, critically, and seamlessly integrate advanced data science methods into the SBS research lifecycle for SUD. Trainees will learn to: (1) Conduct theoretically-informed studies of distributions and ecologies of SUD-related harms using advanced data science methods; (2) Conduct theoretically-informed studies motivating and assessing policies and programmatic interventions that may affect SUD-related harms and services; (3) Disseminate findings to multiple stakeholder communities to strengthen efforts to end SUD-related harms; (4) Critically apply principles of the ethical and responsible conduct of research.